The effect of a housing mobility program on environmental exposures and asthma morbidity among low-income minority children

Children living in poor-urban neighborhoods bear a high burden of asthma morbidity, and there is strong
evidence that housing-related environmental exposures such as pest allergens are a major driver of this
excess asthma morbidity. Historic residential discrimination together with systemic disinvestment in
neighborhoods have contributed to poor neighborhood and housing conditions, which make successful
mitigation of housing-related exposures difficult, and in many cases, impossible. In contrast, housing mobility
programs, where families are supported in moving to less segregated communities, may address the root-
causes of the exposures that drive asthma disparities, while also serving as a tool by which we can parse the
role of various housing and neighborhood exposures and understand their long-term effects on asthma. In our
Mobility Asthma Project (MAP, R01 ES026170-05), children with asthma are followed before and after moving
from high-poverty segregated neighborhoods to low-poverty neighborhoods. We have found, so far, that with
moving, allergen levels and asthma outcomes are markedly reduced. This suggests that housing policy may be
a tool to reduce asthma disparities. However, while these initial findings strongly support the benefit of housing
mobility programs on short-term asthma outcomes, additional questions have emerged which can only be
answered by follow-up of this unique cohort. Our aims here are (1) To compare long-term (4-7 years) asthma
morbidity and home exposures between low-income, minority children with asthma who move to low-poverty
neighborhoods with similar children living in high-poverty neighborhoods, (2) To determine if moving from a
high- to a low-poverty neighborhood is associated with improved lung function growth among the original MAP
participants by repeatedly assessing lung function up to 4-7 years post-move and comparing their lung function
trajectories with a similar population from the URECA cohort and (3) To examine the role of stress, measured
by: a) exposure to neighborhood stressors, b) parental/caregiver stress, and c) child stress in the relationships
between indoor exposures, moving, and asthma morbidity and lung function. The proposed MAP Follow-Up
Study is poised to advance our understanding of the long-term effects of living in poor quality housing in high
poverty neighborhoods on asthma and lung function growth and directly inform the development of policy-
oriented interventions, such as expansion of housing mobility programs, which show great promise for
reducing the disproportionate burden of asthma among minority children with asthma.

Public health relevance
Asthma morbidity continues to be a major public health problem among low-income minority children living in urban neighborhoods, and the major contributors are thought to be exposures to pest allergens and indoor pollution. With this current proposal, we will extend our previous Mobility Asthma Project (MAP, R01 ES026170-05), where we followed children with asthma as they entered into the Baltimore Housing Mobility Program and moved to low poverty neighborhoods, to determine if these reductions in home exposures and asthma outcomes are sustained over a 4 to 7 year follow-up period, whether lung function growth is changed with mobility, and whether parent/caregiver stress may mediate or modify the effects of changes in indoor exposures on asthma outcomes. The proposed project is strongly positioned to both influence housing policy around mobility and has implications for interventions designed to reduce asthma morbidity in children who remain living in high-poverty neighborhoods.